Innovation Corps Administrative Supplement for Magnetic Bronchoscope for Improved Pulmonary Access

One of every 16 Americans will be diagnosed with lung cancer in their lifetime. Each year in the United States
there are nearly 250,000 new diagnoses and 150,000 deaths with an estimated productivity loss in excess of
$20 billion. Thanks to recent advancements in CT imaging, detection of smaller suspicious pulmonary nodules
within distal regions of the lung is now possible. As a result, mortality rates have decreased by nearly 20% due
to earlier initiation of treatment protocols. The ability to safely obtain a viable biopsy sample is critical.
However, despite the availability of better CT imaging, little progress has been made in expanding affordable
tools which can safely access distal regions of the lung to diagnose and stage suspicious nodules.
Percutaneous needle biopsy remains the standard of care used to obtain nodule tissue samples, although the
procedure is associated with pneumothorax complication rates greater than 20%. In contrast, bronchoscopes
are 10X safer when used to acquire biopsies. However, bronchoscopes possess two main limitations which
result in many lung cancers not being successfully diagnosed. First, the relatively large size prevents them
from being able to access most of the lung. Second, because the bronchoscope’s tip is manipulated from
nearly a meter away using complex pull-wire based mechanisms, limited control of the tip is provided which
largely restricts biopsy to nodules within the airway. To improve upon manual bronchoscopes, robotic solutions
have been developed; however, these technologies are difficult to learn, do not greatly improve distal access
or tip control, and are prohibitively expensive (~$500k) for most hospitals. As a result, adoption of robotics for
bronchoscopy has been slow. UNandUP has invented a novel robotic bronchoscopy platform that provides
precise control of the bronchoscope’s tip using a smaller scope diameter than previously possible that enables
safe access into otherwise inaccessible lung regions and the ability to better biopsy nodules not directly in the
airway. By overcoming the complexities of traditional robotic approaches, the proposed technology can be
priced at a fraction of the cost of competing robotic solutions. This will allow advanced lung biopsy capabilities
to be offered to nearly all hospital versus only being available at select institutions. Importantly, the technology
also promises to serve as an exploratory platform for emerging cancer therapies which include gene,
photodynamic, and ablation therapies. The project’s aims include 1) building the robotic workstation, 2) building
a steerable bronchoscope, and 3) assessing performance in CT-based bronchial phantoms.

Public health relevance
Lung cancer is the most common cancer worldwide and the leading cause of cancer death in the US, accounting for 2.1 million new cases each year (229,000 in the US) with 1.8 million deaths (150,000 in the US). Earlier screening and detection drive an increasing rate of interventions to smaller lesions in more remote regions of the lung, and although bronchoscopy is safer than percutaneous intervention, accessing distal lung regions and controlling the bronchoscope’s tip to obtain a viable biopsy are difficult. In this Phase I proposal, UNandUP, LLC (short for “Unmet Needs and Underserved Populations”) will demonstrate proof of concept that its novel and cost-effective robotic platform can extend access into otherwise inaccessible lung territories and improve bronchoscope control, thereby allowing for more efficient and safer biopsies.